EFFECT OF EXERCISE TRAINING OR ALTITUDE ON MAXIMUM OXGEN UPTAKE

Study determinants of V02 max in single leg exercise in normal sedentary subjects, study determinants of blood lactate accumulation during exercise, perform morphometric and biochemical analysis of skeletal muscle, and determine angiogenic growth factor mRNA/protein response to acute exercise.